IOM Round table on Value & Science-driven Healthcare

The Roundtable on Value & Science-Driven Health Care was established by the Institute of Medicine to accelerate the advancement and application of science that will achieve the best possible health and health care outcomes and value for Americans. the Roundtable and its members work in multiple ways to foster progress in particular on three dimensions: Value - transparency & continuous improvement Science - evidence & continuous learning Culture - collaborative ethic, informed choices, shared decisions This work is conducted through two types of activities: 1. Fostering the concepts, understanding, and strategies supporting a continuously learning health system via the Learning Health System Series and related activities. (Description | Publications) 2. Accelerating progress through joint projects by participants in six stakeholder Innovation Collaboratives: Best Practices Clinical Effectiveness Research Evidence Communication Digital Learning Systems Approaches for Health Value Incentives